The Epigenetics of Cytoplasmic Incompatibility

Project Summary:
Wolbachia are a genus of endosymbiotic bacteria that comprise a promising, cost-effective tool to curb arboviral
transmission based on two key facets. First, Wolbachia block pathogenic RNA viruses by inhibiting their
replication in arthropods. Second, Wolbachia selfishly alter sperm and egg via a process termed cytoplasmic
incompatibility (CI) that can drive the bacteria into host populations. CI is expressed as embryonic lethality in
crosses between infected males and uninfected females, but this lethality is rescued in crosses between infected
males and infected females, which are the transmitting sex of Wolbachia. Consequently, CI is deployed in field
trials to either suppress mosquito population sizes or replace uninfected populations with infected individuals
resistant to arboviral infection. We recently discovered pre-fertilization impairments to sperm genome integrity
that underpin the CI drive. The CI-causing Cif proteins CifA and CifB from a prophage region in wMel interact
with developing spermatid nuclei to alter the epigenetically-controlled, histone-to-protamine transition, namely
by increasing histone retention in developing spermatids and decreasing protamine levels in the mature sperm.
The Cif proteins do not paternally transfer to the fertilized embryos, instead the modified sperm in testes with
impaired chromatin integrity transfers to bestow CI. Despite decades of intense research and current applications
to vector control, the mechanistic details of these pre-fertilization impairments remain a central enigma and are
only now subject to investigation. Here, we propose the first, in-depth examination of CI-defining histone marks
and protamine types to test the central hypothesis that the Cif proteins alter epigenetic events during
gametogenesis to cause CI and rescue. In Aim 1, we will use CUT&Tag chromatin profiling to determine CI-
defining, pre-fertilization changes in sperm histone modifications causing histone retention in wMel-infected
Drosophila melanogaster and Aedes aegypti. We will also test the essentiality of these epigenetic changes to CI
by chemically inhibiting histone modifier enzymes. In Aim 2, we will investigate the type and abundance of CI-
defining protamines that are depleted in mature sperm. Knockout and knockdown transgenic experiments will
link CI-defining embryonic death with the necessity of specific sperm protamine genes. Finally in Aim 3, we will
evaluate rescue-defining changes in the gametic chromatin by first characterizing maternal changes in histone
transcripts and protein abundance during oogenesis. We will then determine post-fertilization epigenetic changes
in sperm DNA that orchestrate paternal chromatin decondensation for embryonic viability. We will also validate
the essentiality of epigenetic modifiers to rescue by inhibiting their enzymatic activity. Despite the rising interest
in deploying Wolbachia to curb arbovirus transmission, studies have not yet yielded a refined, molecular
breakthrough uncovering the host epigenetics driving Wolbachia. If successful, the proposed research will (i)
reveal the incipient, host epigenetic events underlying the CI drive system at the heart of vector control strategies
and (ii) provide a significant gateway to eventually engineer CI and rescue via the host arthropod itself.

Public health relevance
Project Narrative: Mosquitoes infected with the natural bacterium Wolbachia are increasingly released worldwide to curb the transmission of pathogenic Zika and dengue viruses to humans. Wolbachia rapidly spread through host populations by manipulating insect sexual reproduction including the development of sperm, eggs, and embryos. This research will characterize, for the first time, the initial epigenetic modifications during gametogenesis and embryogenesis that enable Wolbachia to spread, self-sustain at high frequencies, and protect local communities from mosquito-borne diseases.